Engagement Optimization Unit

Modified Project Summary/Abstract Section
The overall goal of the EOU of the Washington University Participant Engagement and Cancer
Genomic Sequencing Center (WU-PE-CGS) is to conduct ongoing and iterative research to
integrate optimal approaches to participant engagement in the recruitment, consent, follow-up,
and communication of genomic characterization results. The EOU will optimize the engagement
process for genomic characterization of patients diagnosed with three rare cancers or cancers
that require more research, including those that significantly impact populations (e.g., rural) that
require more research on cholangiocarcinoma, multiple myeloma, and early onset colorectal
cancer. The outcomes of research conducted within the EOU will be fully integrated with the
Participant Engagement Unit (PEU) and Genome Characterization Unit (GCU) to optimize
participant experiences throughout the genomic research process. The EOU will support the
overall mission of WU-PE-CGS through the following aims: (1) conduct ongoing evaluation of
participant engagement and ELSI concerns related to genomic testing among low-resourced
populations with rare cancers; (2) conduct a randomized controlled trial to optimize the return of
results process; (3) use an embedded ethics approach to synthesize and address ELSI issues
arising across all units and the Patient Engagement Advisory Board to optimize participant
engagement. The EOU will use an implementation science framework for the main research
objectives. Aim 1 will interview a random sample of participants at various stages in their study
participation (decliners, post-consent, post-disclosure). Aim 2 will expand and test a web-based
decision aid to elicit participants’ values and preferences for receiving results from cancer
genomic sequencing. Participants will be randomized to intervention (Genomics ADvISOR
decision aid) or control (standard discussion). In Aim 3, we will use embedded ethics to explore
ELSI concerns that arise when genetic testing is offered to low-resourced (e.g., rural-residing)
adults with rare cancer. This approach will ensure that ethical issues arising within components
(PEU, EOU, and GCU) will be identified and communicated across the entire center. The
innovation of this project brings rigorous implementation science to the otherwise slow diffusion of
guideline-driven genetic testing and return of results to cancer patients. We will focus our
engagement optimization research on rural and high-risk low-resourced populations that require
more research in cancer genomic analyses and have often been omitted from implementation
science-directed studies in the area of genomic medicine.